Using mixed methods to evaluate self- and other-generated TDM content as predictors of socioemotional well-being in sexual and gender minority (SGM) and non-SGM adolescents

PROJECT SUMMARY – PROJECT 3
The development of socioemotional well-being in adolescence is crucial for mental and physical health.
Technology and digital media (TDM), and especially social media, are highly used among adolescents and hold
risks and opportunities for socioemotional well-being. These risks and opportunities may be more pronounced
in sexual and gender minority (SGM) adolescents. The long-term goal of our research is to promote well-being
for adolescents and young adults by decreasing negative social media activities and amplifying positive social
media activities. The objective of this Project is to understand the types of social media content that adolescents
create (self-generated) and consume (other-generated), and how these social media activities affect
socioemotional well-being. The Aims are: 1) To test bidirectional relationships between self-generated TDM
content and socioemotional well-being; 2) To test bidirectional relationships between other-generated TDM
content and socioemotional well-being; and 3) To compare the self-and other-generated TDM experiences of
sexual and gender minority (SGM) adolescents with those of non-SGM adolescents. The PI, Co-Is, and
Consultant on this Project bring decades of research experience with adolescents and social media. The PI’s
preliminary work has included development of a novel ethnographic approach to directly observed self-generated
social media content and accumulated experience with longitudinal study design in early adolescents. The
proposed Project will use longitudinal data collection over 2 years. The shared participant pool for this P01
program will be leveraged to recruit the sample of 400 adolescents aged 13-15 years at enrollment. Data
collection approaches included online ethnographic observation of participants’ self-generated social media
content, thematic analysis of other-generated content experienced by participants, individual interviews, and
survey administration. These data will be used to test a cross-lagged panel model examining socioemotional
well-being as a predictor and outcome of self-generated and other-generated social media experiences over
time. Qualitative comparison groups will be used to compare self-and other-generated social media experiences
between SGM and non-SGM adolescents. This Project aligns with the current RFA as it tests how TDM usage
impacts social-emotional development and health outcomes in adolescents from diverse backgrounds and
subpopulations.

Public health relevance
PROJECT NARRATIVE – PROJECT 3 Not applicable. Per the Funding Opportunity Announcement PA-HD-22-009, the Project Narrative is not required for the Project or Core components.